Midwest Consortium for Hazardous Waste Worker Training HWWTP

PROJECT SUMMARY/ABSTRACT (HWWTP Component)
The 13 training centers that comprise the Midwest Consortium for Hazardous Waste Worker Training
(MWC) Hazardous Waste Worker Training Program (HWWTP) provide model training to workers and residents
who may be exposed to hazardous substances. The centers deliver training using 43 course curricula
developed and maintained by the MWC. In the last four years, the MWC HWWTP has provided 3,333
programs to 50,850 trainees for 422,347 contact hours using adult-based, action-oriented, results-centered
programming. The goal of the MWC HWWTP is to protect and improve the health and safety of workers and
communities throughout the region it serves. The objective of the program is to increase the knowledge and
skills of the region's workers and residents who may be exposed to known and newly recognized hazardous
materials by facilitating interactive, hands-on training. The specific aims for the MWC HWWTP for the next five
years are to incorporate innovative training strategies and tactics into programming, develop and implement
worker and community member training related to individual resilience, and design and deliver training
programs related to workplace and community resilience. Achieving these aims will be enabled by overall
MWC activities that include facilitating the delivery of model training programs, providing resources to training
centers to offer programming to disadvantaged populations, and modernizing and simplifying training
evaluation. During the 2025-26 program year, the MWC HWWTP component will deliver 981 programs to
18,167 trainees during 163,300 contact hours. For the full five year period, MWC training centers will provide
5,055 HWWTP programs to 93,602 trainees during 841,366 contact hours.